Phase boundaries and liquid structure of concentrated eye lens protein mixtures

Project Summary
Cataract disease, the leading cause of blindness worldwide, is the end result of
increased scattering of light within the human ocular lens. The proposed
research continues to establish the multi-component phase diagram of
concentrated, aqueous eye lens crystallin protein mixtures, together with its
statistical-thermodynamic molecular basis. A combined approach employing x-
ray scattering, nuclear magnetic resonance, static and quasielastic light
scattering, statistical thermodynamic modeling, computer simulation, and neutron
scattering will be used (1) to test predictions of molecularly-detailed models of
gamma crystallin interactions that seek to quantify angle-dependent potentials of
mean force between lens gamma crystallins, (2) by combining top-down and
bottom-up approaches, to study and define how distinct lens beta crystallin
subtypes combine to form the quaternary beta crystallin structures observed
upon isolation from lens cytoplasm, (3) to further study and refine relationships
between molecular features, free energy, light scattering, and liquid structure in
mixtures of two major crystallin classes, as foundations for systematically
studying mixtures that contain three crystallin classes, (4) to study the
thermodynamics, liquid structure, and phase diagram of controlled, concentrated
aqueous mixtures of the three major classes of mammalian lens crystallins.
Each step will involve the training of undergraduate researchers in both
biochemistry and physics, and a physics doctoral student will also participate.
Each step is an essential part of providing a sound molecular understanding of
the light scattering, phase diagram, and dynamics of concentrated solutions and
mixtures of gamma, alpha, and beta crystallin, and as such bears on the
molecular origins of cataract.

Public health relevance
Project Narrative Cataract disease, the leading cause of blindness worldwide, is the end result of increased scattering of light within the human ocular lens. This research seeks to contribute to the molecular basis of eye lens transparency, thereby taking needed steps toward the long-term goals of prevention and inhibition of loss of transparency in cataract. Furthermore, the physical-chemical principles being investigated apply in a larger sense to many molecular features within living cells, and thus can facilitate much broader potential long-term benefits for human health.